A Universal Tool for Unravelling the Requirements for Clinically Relevant Cell-Cell Interactions via In Situ Phenotyping and Tagging of Live Cells

PROJECT SUMMARY - ABSTRACT
Cell-cell interactions drive many of today’s most challenging diseases like cancer, autoimmunity, and
neurological disease. Studying cell-cell interactions is challenging because the cells are alive and remain motile,
and the complexity of downstream analysis increases with every observed interaction event. Today, researchers
study cell-cell interactions using invasive perturbation methods (e.g. CRISPR) or commercial spatial approaches
on FFPE or FF dead tissue samples. While these approaches have their merits, the field would benefit from a
non-invasive, easy-to-use method for live cell identification and on-demand tagging at scale. This proposal aims
to derisk the core elements of a prototype instrument, software, and consumable developed for on-the-fly cell
identification, tagging, and downstream characterization. The live-cell-in, live-cell-out process allows applications
like live cell assays, further cell engineering, and new depths of multiomics discovery not possible with today’s
spatial approaches. The platform will be tested in an end-user’s hands toward the clinically relevant study of the
effects of antigen presentation on T-cell activation. At the core of the proposed application is the tenet that a
better understanding of cell-cell interactions will expose important underlying biological pathways, thereby
increasing targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Cell-cell interactions drive biological processes in metazoans and consequently play a key role in many of today’s challenging diseases. Enabling methods for on-the-fly identification and downstream isolation of live cells engaging in clinically relevant cell-cell interactions would allow a deeper understanding of underlying biology and consequently lead to the discovery of additional druggable targets. We propose an instrument, software, and consumable platform for imaging, identifying, tagging, and isolating live cells engaging in clinically relevant cell- cell interactions at scale.